Developmental Research Project Program

DEVELOPMENTAL RESEARCH PROJECTS PROGRAM PROJECT SUMMARY
The Developmental Research Project Program (DRPP) of the Maine INBRE (ME-INBRE) aims to support
innovative biomedical research and pilot projects led by outstanding faculty researchers at ME-INBRE partner
institutions. The program has three specific aims. 1) Funding: The DRPP will provide competitive funding for
Research Projects (RPs), Pilot Projects (PPs), and Collaborative Pilot Projects (CPPs) that involve students in
innovative biomedical research. RP Leaders, who are newly appointed or early-career faculty, will dedicate 50%
of their effort to their projects. PP Leaders can be faculty members at any career stage from Primarily
Undergraduate Institutions (PUIs), devoting 25% effort. CPP Leaders will form multi-disciplinary teams involving
scientists from different INBRE network institutions. Funding duration varies, with RPs spanning two years and
PPs funded for one year, with the possibility of one competitive renewal contingent on progress. 2) Mentoring:
Project Leaders will be partnered with and receive guidance from experienced mentors. RPs will have both an
internal mentor from their institution and an external mentor in their research field. PPs will typically have a single
mentor. Project Leaders will also participate in workshops on data science, grant writing, lab management, and
other relevant topics, fostering their career development. 3) Evaluation: The DRPP will undergo rigorous
evaluation to ensure its effectiveness. Project Leaders will submit progress reports, and the DRPP Director and
the Evaluation Team will assess project progress toward publications, major grant proposals, and mentoring
effectiveness using a prescribed evaluation matrix. The External Advisory Committee will conduct semiannual
evaluations and provide personalized feedback to the Project Leaders and their mentors, ensuring their
continued success. The ME-INBRE DRPP prioritizes innovative projects, particularly those with data science
components, engaging undergraduate students and leveraging core resources from ME-INBRE and other IDeA
programs in Maine and the region like the Maine COBREs and Northern New England CTR. The DRPP will also
follow the ME-INBRE Plan for Enhancing Diverse Perspectives (PEDP). The program's impact will be to increase
the amount of and capacity for high-quality biomedical research in Maine that is inclusive of diverse perspectives.
It will do so by supporting innovative investigator-initiated research and pilot projects, both standalone and
collaborative, and through effective mentorship and research oversight. The program will also promote
collaborations across ME-INBRE network institutions.